Molecular Mechanisms regulating Primordial Follicle Formation

PROJECT SUMMARY/ABSTRACT
Despite its importance to the continuation of species, the differentiation of primordial
germ cells into functional oocytes is poorly understood. Primordial germ cells begin to
differentiate into oocytes during embryonic development in the mouse. The oocytes develop in
clusters called germline cysts, a conserved phase of oocyte development in both vertebrates
and invertebrates. Oocytes progress through prophase I of meiosis and arrest at the diplotene
stage. They then undergo primordial follicle formation during which germ cell cysts break apart
into single oocytes (cyst breakdown) and granulosa cells migrate around individual oocytes to
form primordial follicles. During the process of cyst breakdown, a subset of cells in each cyst die
with only a third of the initial number of oocytes surviving to form primordial follicles. The
mechanisms that control assembly of primordial follicles are not well understood. The long-term
goal is to understand molecular and cellular mechanisms used to establish the primordial follicle
pool in the mouse ovary. Published work from the applicant’s lab using ovary organ culture
suggests that signaling through the receptor tyrosine kinase, KIT, promotes the assembly of
primordial follicles. In addition, preliminary data suggest that KIT can signal through the
phosphoinositide 3-kinase (PI3K) pathway to promotes primordial follicle formation but that
other signals besides KIT such as insulin may be important. The objective of this proposal is to
understand the role to understand the role of insulin in primordial follicle formation. The central
hypothesis of the proposed research is that in addition to KIT signaling, insulin signaling
promotes primordial follicle assembly through the PI3K signal transduction pathway activating
molecules that promote follicle formation and repressing molecules that maintain oocytes in
cysts. The specific aims of this research are to: 1) elucidate the role of insulin signaling in
primordial follicle formation; and 2) examine primordial follicle formation in a mouse model of
gestational diabetes. These goals will be achieved through techniques including
immunohistochemistry, confocal microscopy, ovary organ culture, and genetics. Research
proposed in the current application is significant because it will enhance current knowledge by
elucidating the mechanisms important to establish the primordial follicle pool. Results obtained
in this grant will help improve research efforts in ovarian biology and in treatment of conditions
causing female infertility such as primary ovarian insufficiency.

Public health relevance
PROJECT NARRATIVE The pool of primordial follicles present at birth represents the total population of oocytes available to a female during her entire reproductive life. Research proposed in this application will elucidate insulin signaling mechanisms regulating primordial folllicle formation. This research will make a fundamental contribution to the understanding of the establishment of the primordial follicle pool and shed light on female reproductive issues such as primary ovarian insufficiency, reproductive aging, menopause, and ovarian cancer.